Research Infrastructure Core

PROJECT SUMMARY (Research Infrastructure Core)
The Research Infrastructure Core (RIC) at Jackson State University (JSU) RCMI Center for Health Disparities
Research (RCHDR) is designed to accelerate discoveries in basic, behavioral, clinical and/or translational
research on important health disparity issues of concern to minorities and underserved communities. The RIC
fully supports the RCHDR vision of further developing a state-of-the-art biomedical infrastructure that enables
JSU investigators to become more competitive in obtaining independent research grants from NIH and other
funding agencies. Its overarching goal is to provide a robust infrastructure and research resources, for RCHDR
investigators to implement innovative research aimed at improving minority health and reducing health
disparities. This primary goal of RIC will be achieved through the implementation of four specific aims that
include: Specific Aim 1. Enhance the biomedical research infrastructure of specialized core modules
including the Analytical, Animal, Bioinformatics and Biostatistics, Molecular and Cellular Biology, and
Cellomics and Toxicogenomics laboratories. Approach: Upgrade the research infrastructure and provide a
modern and reliable shared instrumentation facility that enhances the research environment, promotes
research collaborations, and strengthens the research competitiveness of RCHDR investigators. Specific Aim
2. Offer RCHDR investigators a wide range of state-of-the-art equipment, and bioinformatics and
biostatistics services for basic, behavioral and/or clinical research. Approach: Provide research
instrumentation as well as technical, methodological, and personnel support to all current and future
investigators of both Research and Pilot projects. Here, we plan to support the design, implementation, data
collection and analysis, and reporting of the three specific research projects included in this grant application,
as well as the three to five pilot projects that will be funded through the Pilot Project Program. Specific Aim 3.
Provide facilities access as well as training and support services to RCHDR investigators. Approach:
Promote access to and facilitate the utilization of research resources thereby maximizing utilization of
advanced technologies and increasing efficiency and productivity. Specific Aim 4. Foster professional
development and interdisciplinary collaborations in biomedical research. Approach: Organize project-
specific mentoring and professional development workshops. Facilitate collaborations between RCHDR
investigators and investigators from various departments, within JSU and other research-intensive institutions.
By achieving the above stated specific aims, the RCHDR RIC will serve as a strong catalyst for basic
biomedical, behavioral and/or clinical research at JSU. It will provide a critical support to increase quality,
productivity, cost-effectiveness, and biomedical research outcomes of all RCHDR investigators.

Public health relevance
PROJECT NARRATIVE (Research Infrastructure Core) In this U54 grant proposal, we propose the consolidation of existing multiuser core laboratories to create a comprehensive Research Infrastructure Core (RIC) that will accelerate discoveries in basic, clinical and/or translational sciences, in an effort to address important health disparity issues of concern to minorities and underserved communities. The proposed RIC will provide RCHDR investigators and the scientific community at JSU with a robust, collaborative, and standardized resource for the efficient implementation of their biomedical research projects. This strategic plan fully supports the RCHDR vision of developing a state-of-the- art biomedical infrastructure that enables JSU investigators to become more competitive in obtaining research grants from NIH and/or other funding agencies.